Enhancement of exposure therapy, modeled by extinction learning in rats, using transcranial direct current stimulation

Posttraumatic stress disorder (PTSD) is debilitating illness, impairing health, well-being, and productivity of
25-30% of combat veterans. Currently approved drug treatments are largely ineffective. Behavioral therapies,
including exposure therapy, can be more effective for some, but efficacy is also limited by many factors, including
the duration of treatment and the anxiety and distress it can produce, both of which contribute to a high rate of
attrition. Many patients cease treatment before completing the full course of therapy, so anything that can
enhance the effectiveness of exposure therapy and accelerate clinical improvement would be highly beneficial.
Thus, there is a need to identify and investigate new adjunct treatments that can enhance the efficacy of
exposure therapy. Exposure therapy is a form of extinction learning. To investigate the mechanisms underlying
the beneficial effects of exposure therapy and identify potential entry points for intervention that may enhance it,
we have developed extinction learning as a valid preclinical model of exposure therapy in rats. We showed that
treating rats with extinction learning was effective in reversing several behaviors impaired by exposure to chronic
unpredictable stress (CUS), that model key symptom dimensions of PTSD. However, our standard 16-trial
extinction model was fully effective in restoring stress-impaired behaviors that resemble components of PTSD,
which made it impossible to detect improvements in efficacy. Therefore, to be able to detect increased efficacy
with adjunct treatment, we developed a sub-effective 8-trial extinction procedure, and validated its ability to detect
improved efficacy with adjunct treatment. The first purpose of the current renewal is to now use this sub-effective
extinction model to test transcranial direct current stimulation (tDCS), a non-invasive, painless, easily
administered neuromodulatory treatment, as a potential adjunct strategy to enhance the plasticity induced by
extinction in the infralimbic cortex (IL), a sub-region of ventral medial prefrontal cortex (mPFC) that has been
implicated in PTSD. Aim 1 will test the hypotheses that tDCS will: a) enhance the efficacy of 8-tone extinction in
restoring cognitive flexibility mediated in IL, and improve other PTSD-like behaviors mediated by sub-cortical
targets of IL; b) enhance the rescue of afferent-evoked responses in mPFC that have been compromised by
CUS; and c) enhance the activation by 8-tone extinction of mPFC and its downstream targets that mediate
stress-compromised behaviors. We previously showed that activation of the projection from ventral hippocampus
(vHipp) to mPFC is important for the therapeutic effects of extinction. In the last grant period, L-655,708, a
negative allosteric modulator of a5-GABAA receptors expressed selectively in the hippocampus, was studied as
a potential therapy for stress-impaired behaviors. Because a5 NAMs increase vHipp activity, in Aim 2 we will
test TB21007, a more selective and potent a5-NAM, as a potential pharmacological adjunct treatment to enhance
the efficacy of extinction. The impact of this project will be to identify readily translatable adjunct treatments that
can make exposure therapy better and faster, enhancing the quality of life for veterans struggling with PTSD.

Public health relevance
Posttraumatic Stress Disorder (PTSD) is serious and debilitating, with a particularly negative impact on veterans. Current treatments are inadequate, and there is a need to identify new, more effective approaches. Behavioral therapies, including exposure therapy, can be effective, but little is known of their mechanisms, and efficacy is limited. To address this need, we established extinction learning as a valid model of exposure therapy in rats, then developed a partial, sub-effective extinction procedure to investigate potential adjunct treatments that may enhance the efficacy of exposure therapy. Using this model, the primary purpose of this proposal is to test transcranial direct current stimulation (tDCS), a non-invasive neuromodulatory treatment, as a potential adjunct approach to enhance the efficacy of extinction. Secondly, we will test TB21007, a pharmacological candidate that we believe shares mechanisms with tDCS. The potential impact of this research is to make exposure therapy better and faster, improving treatment outcomes for PTSD, and enhancing quality of life for veterans.